Ribosome regulation, inhibition, and quality control mechanisms

PROJECT SUMMARY
Ribosomes are the complex, cellular machinery responsible for promoting mRNA-directed translation of
the genetic code to produce all proteins in every living organism. The ribosome must select correct tRNAs
to decode the mRNA, facilitate peptide bond formation, and then move the tRNAs through its three
functionally distinct tRNA binding sites in a dynamic and exquisitely orchestrated manner. We study the
regulation, inhibition, and quality control mechanisms of the ribosome using integrated biochemistry and
structural biology approaches. In this proposal, we extend our novel insights into the regulation of the
ribosome by studying three themes. The first theme focuses on understanding translation fidelity events
including miscoding, quality control, and processivity errors including mRNA frameshifting caused by
tRNAs lacking posttranscriptional modifications and complex mRNAs. The second theme focuses on
understaffing ribosome rescue, an event that occurs when ribosomes stall primarily because of defective
mRNAs. And finally, the third theme focuses on the role of diverse bacterial ribonucleases including toxins
and newly identified ribonucleases that inhibit translation to cause growth inhibition of ribosome
hibernation. We will accomplish these questions using biochemistry and structural biology approaches to
determine the mechanistic basis for which ribosomes are regulated.

Public health relevance
PROJECT NARRATIVE The goal of this project is to understand how the ribosome is regulated and inhibited using biochemistry and structural biology to understand molecular mechanisms.